Targeting the long isoform of the prolactin receptor to treat autoimmune diseases and B-cell malignancies

PROJECT SUMMARY
Early interventions for high-risk B-cell malignancies, including diffuse large B cell lymphoma (DLBCL), Burkitt's
Lymphoma (BL), and B-cell acute lymphoblastic leukemia (B-ALL), remain an urgent clinical need. Development
of such interventions requires a deep understanding of the molecular mechanisms underlying the evolution, i.e.,
initiation, establishment, and sustenance, of these malignancies. B-cell malignancies are initiated >5-fold more
frequently in patients suffering from refractory autoimmune B-lymphoproliferative disorders such as systemic
lupus erythematosus (SLE), making SLE a relevant disease model to study initiation of B-cell neoplasms. The
hormone prolactin (PRL) is known to exacerbate the symptoms of SLE, enhance survival of lymphoid cells, and
promote the expression of the protooncogenes MYC and BCL2 in these cells. Whether PRL contributes to
evolution of B-cell malignancies was unknown. PRL receptors (PRLRs) are type I cytokine receptors that
have long (LF), intermediate (IF, only in humans) and short (SF) isoforms generated by alternative splicing.
Increased expression of the LF/IF relative to the SF PRLRs on cells leads to cell proliferation and survival,
whereas increased expression of SFs relative to LF/IF inhibits proliferation, promotes differentiation, and induces
apoptosis. We hypothesized that PRL, by signaling specifically through the pro-proliferative and anti-apoptotic
LF/IFPRLR, promotes the malignant transformation of B cells, and establishes and sustains the growth of overt
B-cell malignancies. To test our hypothesis, we measured changes in B cells in vivo in SLE- and DLBCL/BL-
prone mouse models and in vitro in human B-cell malignancies after specifically knocking down expression of
the LF/IFPRLR using a non-toxic splice modulating oligomer (SMO). The LFPRLR SMO prevents the synthesis
of the LFPRLR in mice and the LF/IFPRLR in humans without affecting the SFPRLRs. Knockdown of
LFPRLR reduced the numbers of pathogenic B-cell subsets in SLE- and DLBCL/BL-prone mice and lowered the
risk of B-cell transformation in SLE-prone mice by downregulating expression of the activation-induced cytidine
deaminase (AID) enzyme, whose overexpression we previously showed, drives the evolution of B-cell
neoplasms. We found that overt human B-cell neoplasms aberrantly express autocrine PRL and sometimes only
the LF/IFPRLR. Knockdown of LF/IFPRLR in overt B-cell malignancies reduced cell viability, downstream STAT3
activation, and expression of MYC and BCL2. Our preliminary findings warrant detailed studies of molecular
pathways underlying the disturbances in B cells downstream of LF/IFPRLR in SLE-prone mice that are
vulnerable to transformation (Aim 1), in mice with pre-malignant B-cell clones prone to overt B-cell malignancies
(Aim 2), and in overt human B-cell neoplasms (Aim 3). Our research will solidify isoform-specific suppression
of the production of LF/IFPRLR as a therapeutic strategy in SLE that concurrently lowers the incidence of B-
cell malignancies in these patients (Aim 1), in people with pre-malignant and indolent B cells who are vulnerable
to developing aggressive B-cell malignancies (Aim 2), and in overt B-cell neoplasms (Aim 3).

Public health relevance
PROJECT NARRATIVE Patients with B-cell mediated autoimmune lymphoproliferative diseases, including systemic lupus erythematosus (SLE), and those with indolent, pre-malignant B-cell clones are vulnerable to developing aggressive B-cell malignancies. Our proposed studies will delineate how the hormone, prolactin (PRL), by signaling specifically through the long and intermediate isoforms of the prolactin receptor (LF/IFPRLR), drives the evolution of high- grade B-cell malignancies in vulnerable individuals and sustains these malignancies. Our investigations will identify isoform-specific knockdown of the LF/IFPRLR as an effective, less-toxic, and affordable approach to treat a broad spectrum of B-lymphoproliferative disorders with widely divergent outcomes.